Characterization of PBIP1, a novel polo-box-binding protein at the kinetochores

Members of the polo subfamily of Ser/Thr protein kinases have been shown to play critical roles for mitotic progression in various eukaryotic organisms. We have previously demonstrated that the evolutionarily conserved polo-box domain (PBD) of polo kinases is essential in targeting the catalytic activity of the polo kinases to specific subcellular structures. In an effort to identify the polo-box-binding proteins, we carried out yeast two-hybrid screening using the PBD of the mammalian polo-like kinase Plk1 as a bait and isolated a novel kinetochore-associating protein that we termed PBIP1 (for Polo-Box-Interacting Protein 1). PBIP1 interacts with endogenous Plk1 in vivo under physiological conditions and appears to be a kinetochore-specific mitotic inhibitor that is phosphorylated and degraded by Plk1 in mitosis. Expression of the non-degradable PBIP1 lacking the Plk1-dependent phosphorylation sites induces a mitotic arrest, indicating that degradation of PBIP1 is required for proper mitotic progression. PBIP1 binds to myeloid leukemia factor 1 (MLF1), whose deregulation by fusing with nuclear phosmin (NPM) promotes the development of acute myeloid leukemia (AML) from myelodysplasia (MDS). Thus, down-regulation of PBIP1 by MLF1 could be an important step for the development of AML. In line with these observations, we identified multiple mutations in the PLK1 ORF of leukemia cell lines. These findings raise the possibility that deregulation of Plk1 leads to improper PBIP1 function and the genesis of leukemia, and provide new views on the role of polo kinase in the development of leukemia and other tumoregenesis.